Aryl hydrocarbon receptor (AHR) deficiency in a frog model of dioxin toxicity

Project Summary. The Aryl Hydrocarbon Receptor protein (AHR) underlies multiple human disease states.
AHR is a ligand-activated transcription factor that mediates toxicity of numerous environmental contaminants,
including dioxin-like compounds such as 2,3,7,8 tetrachlorodibenzo-p-dioxin (TCDD) from industrial waste and
polynuclear aromatic hydrocarbons in weathered crude oil and cigarette smoke. AHR also plays roles in
ordinary development of liver, cardiovascular system, and oocytes, disruption of which by toxic agonists or
mutation can cause disease in adults. African clawed frogs, pseudotetraploid Xenopus laevis and diploid X.
tropicalis, are widely studied aquatic models of vertebrate development. Xenopus is also used in
developmental toxicity screens at two life stages. FETAX (Frog Embryo Teratogenesis Assay-Xenopus)
detects acute developmental toxicity resulting from chemical exposure at early life stages. The Amphibian
Metamorphosis Assay (AMA) models late fetal development in humans, measuring chemical disruption of
remodeling of a tadpole to a froglet. The human-health relevance of AHR function in developmental toxicity is
poorly understood in frogs, limiting the validity of these assays for human risk assessment. An understanding
of the fundamental developmental and cellular functions of frog AHRs is essential for the use of this model in
toxicological studies. The overall objective is to use genome-edited, AHR-deficient Xenopus models, including
ahr-null X. tropicalis animals and X. laevis cell lines, to identify specific functions of AHRs in developing frogs
and cultured cells. Studies under Aim 1 will identify functions of AHR in X. tropicalis development. We will
characterize phenotypes displayed in ahr-null frogs, using the FETAX regimen to compare frequency and
severity of typical developmental defects in ahr-null and wild-type embryos, including survival, length, axial and
head deformities, and edemas. We will also test the hypothesis that ahr-null frogs display hepatic and ovarian
phenotypes typical of AHR-/- mice, comparing morphology and histology. Finally, we will use a suite of assays
to determine how loss of ahr alters tissue remodeling during metamorphosis. We will couple morphological
endpoints with RNAseq studies to determine gene expression alterations underlying phentoypes. In Aim 2, we
will use X. laevis cell lines lacking one of the two ahr paralogs in this species, testing the hypothesis that
individual AHR paralogs play distinct role in cell cycle regulation. We will compare slow-growing ahr1a-null
mutants with ahr1b-null and wild-type XLK-WG cells by flow-cytometry, establishing cell cycle distribution of
each. We will also test the hypothesis that ahr1a-null cells are prone to apoptosis. Preliminary data suggest
that AHR1a and AHR1b regulate distinct sets of gene targets. We will test this hypothesis in RNAseq studies.
This AREA project will provide comparative insight into the pathways of AHR-mediated developmental toxicity
shared among vertebrate models. It will also lend mechanistic underpinning to frog developmental toxicity
screens such as FETAX and AMA, improving their validity for human risk assessment.

Public health relevance
Project Narrative The aryl hydrocarbon receptor (AHR) protein is required for the toxic effects of a wide range of chemical pollutants, many of which may cause defects in the development of embryos and fetuses. Frog embryos and tadpoles are frequently used to identify chemicals that alter development. This project seeks to determine if the AHR functions in the same way in humans and in the frog models used to predict the toxic effects of chemicals and environmental samples in people.